DRCR Network

Project Summary
The DRCR.net is a research network dedicated to facilitating multicenter clinical research of diabetic
retinopathy (DR), age-related macular degeneration (AMD), hereditary retinal degenerations and other retinal
diseases. The Network’s mission is to identify, create, conduct, analyze and disseminate high quality clinical
studies that lead to a better understanding of retinal diseases, advance their treatment, and improve the lives
of individuals with retinal pathology. The DRCR.net operates through a highly collaborative network comprised
of a Coordinating Center, two Network Chairs, over 100 clinical sites, and other central resource groups such
as image reading centers. This standing infrastructure, along with the substantial clinical and scientific
expertise of its investigators, allows the Network to be highly efficient and effective in the design,
implementation and reporting of large-scale, ophthalmic clinical studies of major public health priority.
In the United States alone, it is estimated that nearly 20 million Americans are affected by retinal
pathology from DR, AMD, retinal vein occlusion, myopic choroidal neovascularization, retinopathy of
prematurity, or inherited retinal diseases. The US economic burden from retinal disorders totals as much as
$8.7 billion per year. The DRCR.net is uniquely poised to make impactful and continuing contributions to the
fight against vision loss from retinal diseases including DR and AMD. Since its inception in 2002, DRCR.net
has successfully made numerous and substantial contributions to the improvement of visual outcomes in
diabetic patients. DRCR.net studies have addressed efficacy of novel therapies, cost effectiveness, patient
quality of life, novel methods of retinal imaging and multiple aspects of visual function with major direct impact
on clinical care guidelines and practices worldwide. The uniqueness of the Network and its efficiencies of
scale allow the performance of protocols using money from the NIH, industry, and foundations. These
protocols often involve trials that would not be done by industry and would not be feasible with solely NIH
funding. Such protocols have included comparative effectiveness studies, trials supportive of new indications
for approved drugs, and studies testing new therapies. The major goals of the DRCR.net over the next 5 year
period include 1) completing the 7 studies currently ongoing in the DRCR.net, 2) continuing to develop and
implement protocols in a rapid and efficient manner while maintaining absolute scientific rigor and integrity, 3)
maintaining a transparent and open collaborative Network and 4) continuing to effectively disseminate trials
results, treatment algorithms, and datasets to clinicians and other researchers. Given its previous
accomplishments, robust organization, high visibility within the retinal community and strong enthusiasm of its
investigators and personnel, the DRCR.net anticipates success in designing and implementing clinical studies
over the next 5 year period that will substantially and positively impact our ability to preserve and improve
vision in patients with retinal disease in the US and across the globe.

Public health relevance
Project Narrative (3 Sentences) Visual impairment and blindness from retinal diseases remain a significant public health problem that continues to grow in epidemic proportions in the United States and globally despite advances in treatment. The DRCR.net is collaborative research network dedicated to multicenter clinical research of diabetic retinopathy, age-related macular degeneration, hereditary retinal degenerations and other retinal diseases of public health importance through the identification, creation, implementation, analysis and reporting of high quality clinical studies that lead to a better understanding of retinal diseases, advance their treatment, and positively improve the lives of individuals with retinal pathology. DRCR.net studies addressing novel treatments for diabetic macular edema and proliferative diabetic retinopathy have already had a major direct impact on clinical care guidelines and practices worldwide for diabetic eye disease, making the Network uniquely poised for further impactful contributions in the fight against vision loss from retinal diseases.